Glucose energy metabolism in the growth and survival of B lymphocytes

Lymphocytes use considerable amounts of energy to maintain survival and to support growth and effector functions in response to antigen challenge. Aberrant glucose energy metabolism can contribute to autoimmune disease and lymphomas. During the past three decades the role of the B-cell antigen receptor (BCR) in promoting B-cell growth and development has been established. It is also clear that co-receptors (e.g., IgG Fc receptor, FcγRIIB) can negatively modulate both Ag-dependent and Ag-independent growth responses. An appreciation for FcγRIIB in the maintenance of peripheral tolerance is highlighted by the observation that its deletion can result in autoantibody production and autoimmune disease. BCR and FcγRIIB mediated control of lymphocyte function likely requires re-programming of metabolism;however, virtually nothing is known about how signal input from these receptors modulate cellular metabolism or the biological significance of such regulation. On this point, we have recently discovered that the BCR possesses the capacity to reprogram glucose metabolism in real-time to meet the changing bioenergetic and de novo macromolecular synthetic demands associated with B lymphocyte activation. This is achieved by phosphatidylinositol 3-kinase (PI-3K)-dependent signaling that targets several essential rate-limiting enzymes involved in de novo lipogenesis (via activation of ATP citrate lyase, ACL), and entry into the oxidative pentose phosphate pathway (via induction of glucose 6-phosphate dehydrogenase (G6PD) gene expression) to support B-cell growth and DNA replication, respectively. We have also uncovered a novel pathway that links FcγRIIB engagement to decreased glycolysis, a response remarkably similar to decreased glycolytic flux observed upon removal of growth factors from mammalian cells that leads to initiation of apoptosis. Our results suggest that the rate-limiting glycolytic enzyme, phosphofructokinase-1 (PFK-1) is inhibited following FcγRIIB engagement. The central goal of this application is to delineate the molecular regulation of glucose energy metabolism involved in B lymphocyte function and growth responses by signal input from the BCR and FcγRIIB. The proposed studies will seek to test two specific aims. Aim I will elucidate the molecular regulation of ACL activation with respect to BCR-dependent signaling. Aim II will elucidate the molecular mechanisms underlying inhibition of glycolysis following FcγRIIB engagement. Information gathered from this project will also help to distill how dysregulation of glucose metabolism contributes to aberrant B-cell responses and may identify metabolic targets for the development of therapies to treat certain immune diseases characterized by uncontrolled expansion of B cells.

Public health relevance
Aberrant glucose energy metabolism can contribute to autoimmune disease and lymphomas. This proposal represents an opportunity to delineate the molecular mechanisms underlying how growth -promoting (B-cell antigen receptor) and -inhibitory (FcRIIB) signal input modulates glucose energy metabolism and to understand the biological significance of such regulation in B cells. Information gathered from this project will also help to distill how dysregulation of glucose metabolism contributes to aberrant B-cell responses.